Project 3: Preclinical metabolic imaging of molecular alterations of meningiomas

PROJECT 3: PROJECT ABSTRACT
Meningiomas are the most common primary brain tumors in adults. Integrated genomic, epigenomic and
proteomic analyses of patient biopsies have identified biological groups of meningiomas with distinct clinical
outcomes and molecular drivers. Merlin-intact meningiomas have the best outcomes with the least risk of
recurrence and are distinguished by expression of the tumor suppressor NF2. Immune-enriched tumors undergo
loss of NF2 and have an intermediate risk of recurrence. NF2 loss combined with expression of the transcription
factor FOXM1 is observed in aggressive hypermitotic tumors with the highest risk of recurrence. Identifying
biomarkers of NF2 loss, alone or combined with FOXM1 expression, has the potential to enable non-invasive
stratification of meningioma patients according to their risk of recurrence.
Many oncogenes and tumor suppressors, including NF2 and FOXM1, rewire cellular metabolism in a manner
that can be non-invasively visualized by magnetic resonance spectroscopy (MRS). 1H-MRS quantifies steady-
state metabolite concentrations and is in clinical use. Hyperpolarized 13C-MRS enables in vivo imaging of
dynamic metabolic activity and is in clinical trials in brain tumor patients. In combination, 1H- and hyperpolarized
13C-MRS provide a comprehensive view of the metabolic state of tumor tissue in vivo. Our preliminary studies in
isogenic models identify NF2 and FOXM1 driven differences in amino acid, glucose, and phospholipid
metabolism that can be interrogated using 1H-MRS, hyperpolarized [1-13C]-pyruvate and hyperpolarized [1-13C]-
alanine. Based on these studies, we propose to identify 1H-MRS (Aim 1) and HP 13C-MRS (Aim 2) biomarkers
of NF2 loss and FOXM1 expression in patient-derived meningioma cells, tumor xenografts, and patient biopsies.
We will then mechanistically validate our metabolic biomarkers by delineating the molecular pathways that link
NF2 and FOXM1 to meningioma metabolism (Aim 3).
Our studies are innovative because we will, for the first time, leverage metabolic reprogramming for non-invasive
imaging of meningiomas. Our proposal is significant because our biomarkers have the potential to non-invasively
discriminate between clinically relevant molecular groups of meningiomas. By doing so, they will provide
physicians with the ability to determine whether an individual patient’s tumor is likely to recur and tailor the
treatment plan accordingly. In essence, our studies will enable precision imaging that has the potential to
enhance outcomes and quality of life for meningioma patients.

Public health relevance
PROJECT 3: PROJECT NARRATIVE Advances in genomics have uncovered molecular drivers of clinically relevant biological groups of meningiomas. Our studies will identify metabolic biomarkers that can be used to interrogate these molecular characteristics in a non-invasive manner. Clinical translation of our studies will provide physicians with much-needed tools for stratifying and monitoring meningioma patients.